Reproductive Health Equity in Afghan and Syrian newcomers through digital health literacy

Abstract
Sacramento County, California, is one of the counties with the largest arrivals of Arabic-speaking refugees
and Afghan and Iraqi special immigrant visa holders (SIVs) in the nation. Post-resettlement unemployment
and poverty, poor English skills, socioeconomic pressures, cultural differences, lack of familiarity with
preventive services, and inability to navigate the maze of the US health care system pose substantial barriers
to refugee access to needed reproductive health (RH) care leading to disparities in maternal and infant
health outcomes and to higher cervical cancer rates. An important factor to achieve health equity for
refugees and SIVs is access to accurate and understandable information on sexual and reproductive health
needs and services. In this 3-year study. With expert and outreach support from the Digital Scholarship
Services of the University of California, Irvine (UCI) and the Sacramento Public Library, the California's
Refugee Reproductive Health Network (ReproNet) will leverage its solidly established regional academic –
refugee community partnerships to enhance Afghan and Arab refugee women's knowledge and access to
accurate and linguistically appropriate RH information. Key ReproNet partners in this study will be the
University of California, Davis and Muslim American Society Social Services Foundation (MAS-SSF). In this
project, ReproNet will aim to: (1) Create a publicly-available digital repository of multilingual
reproductive health resources (Dari, Pashto, Arabic) for Afghan and Arab refugee populations. Links to
the materials of the repository will be posted on ReproNet’s social media pages and channels. The repository
will be housed at the UCI DSS which will also maintain and store the resource materials beyond the project
period. (2) Enhance Afghan and Arab refugee’s reproductive health literacy (RHL) in California through 12
in-person training sessions with the Sacramento Public Library and MAS-SSF (3 each in Dari, Pashto, Arabic
and English) and 12 on-line training sessions offered via zoom or Facebook and (3) Increase the capacity
of refugee providers to integrate reproductive health literacy in their programs. We will evaluate the
project through google analytics, session evaluations, and pre- and post RHL and provider training
assessments. An enhanced literacy and access to digital health information and library resources
nationwide will strengthen refugee women’s capacity to obtain, process, and understand the basic RH health
information needed to make optimal health decisions for themselves and their families.

Public health relevance
Summary In this 3-year study, California’s Refugee Reproductive Health Network (ReproNet) will aim to (1) Create a publicly-available digital repository of multilingual reproductive health resources (Dari, Pashto, Arabic) for Afghan and Arab refugee populations (2) Enhance Afghan and Arab refugee’s reproductive health literacy in California through 24 in-person and on-line training sessions and (3) Increase the capacity of refugee programs to integrate RH literacy in their programs.